Crowdsourcing Mental Health with a Web-based peer-delivered intervention

PROJECT SUMMARY/ABSTRACT About 25% of the U. S. population concurrently suffers from a mental illness, yet the majority do not receive treatment. Some people lack access to treatment because of structural barriers, e.g., cost, provider shortages, or transportation limitations. Others do not seek treatment because of attitudinal barriers, e.g., desire for self- reliance or fear of stigma. Novel options for prevention and treatment are needed to address these barriers. Accordingly, Objective 3 of the NIMH Strategic Plan is to Develop New and Better Interventions that Incorporate the Diverse Needs and Circumstances of People with Mental Illnesses. This application proposes to develop an intervention, Crowdsourcing Mental Health (CMH), that responds to this objective. CMH is designed to overcome several treatment barriers in order to (1) treat mild to moderate mental illness, (2) prevent onset and relapse, and (3) increase general psychological well-being. In CMH, peers suffering from mental illness (or those who wish to maintain mental health or increase well-being) will complete an online training in providing an empirically informed intervention. Subsequently, the two peers will deliver the intervention to each other. This technology-supported and peer-delivered approach eliminates barriers of cost, travel, and practitioner availability. CMH may also circumvent attitudinal barriers, allowing participants to feel self-reliant and avoid stigma. The proposed project has two aims: (1) prototype CMH's Web-based training, drawing on research on mental health-promoting processes, psychotherapy change mechanisms, and online education, and (2) test the training to determine its acceptability and efficacy in teaching the care provider role for the CMH program. (The present proposal does not test the full intervention, but instead aims to confirm whether online training can teach the identified caregiving skills. This step is needed prior to a full pilot trial because, if the training does not teach these skills, the intervention is unlikely to be effective. A pilot trial is planned after the conclusion of this award.) Aim 1 will apply the findings that mindfulness and social support are associated with mental health, perhaps through facilitating emotion regulation, which is disrupted in most mental illnesses. The training, then, will be designed to enhance skills of raising a partner's mindfulness and providing supportive statements and avoiding toxic ones. In Aim 2, adults with mild psychopathology will undergo the training. Before and after training, they will participate in mock CMH sessions with a researcher and their performance will be evaluated. They will also provide feedback on the training. This project lays the groundwork for testing the full CMH program's efficacy for various mental disorders and will train the applicant to become an independent scientist who investigates processes promoting mental health and translates findings into innovative treatments. CMH can have a positive impact by reducing the burden of mental illness, treating mild to moderate mental illness and preventing onset and relapse in people who are unable or unwilling to seek traditional treatment.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health insofar as it is the first step to creating and disseminating an intervention that can reduce the burden of mental illness by treating and preventing mental illness in individuals who remain unserved by currently available interventions. This research will also inform the design of other health-promoting interventions by revealing effective development strategies. Finally, by contributing to the literature on training in health-promoting interpersonal skills, this research can inform the construction of therapist training programs, social skills interventions, and interventions for couples and families, all of which can have a cumulative positive impact on public health. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Debilitating and costly mental illnesses are common: in the U.S., almost half of the population will experience at least one major lifetime mental illness, with a quarter of the population meeting criteria for a disorder every year (Kessler & Wang, 2008). These rates actually underestimate disease burden because they omit subthreshold syndromes and adjustment disorder (Kazdin & Blase, 2011). Unfortunately, currently available treatments do not adequately address this enormous burden of mental illness. In fact, only a third of those with a mental disorder receive treatment (Kessler et al., 2005). Some individuals lack treatment access because of structural barriers (e.g., cost, shortages of local providers, etc.); others do not seek treatment because of attitudinal barriers (e.g., desire for self-reliance, stigma; etc.; Mojtabai et al., 2011; Prins et al., 2008). Therefore, new options for the treatment and prevention of mental illness are sorely needed to address these barriers and thereby serve a broader portion of the population. Informed by this need, my long-term goal is to develop, test, and disseminate an intervention, "Crowdsourcing Mental Health" (CMH), which has the potential to overcome several barriers and to (1) treat mild to moderate mental illness, (2) prevent onset and relapse, and (3) increase general psychological well-being. CMH will use individuals' existing social networks and Web-based technology, rather than in-person visits to professionals, thus eliminating barriers of cost and practitioner availability. Because CMH does not involve a professional and will not be marketed overtly as a treatment for mental illness, it may also circumvent attitudinal barriers to treatment seeking, allowing participants to feel self-reliant and to avoid stigma. CMH is designed to increase mindful self-awareness and perceived social support, both of which are strongly associated with mental and physical health (Sedlmeier et al., 2012; Uchino et al., 2012). Theory and research suggest that these two foci exert their effects by promoting emotion regulation (Hölzel et al., 2011; Marroquín, 2011), which is disrupted in most mental disorders (Kring & Sloan, 2010). In CMH, participants will seek a peer who is also interested in the program. Both dyad members will complete an online training to act as a "care provider"; this training will teach counseling skills focused on (1) raising their partner's self-awareness, and (2) providing interpersonally supportive statements and avoiding toxic ones. Participants will then meet weekly and take turns in the roles of care provider and care recipient. Throughout the process, they will track their symptoms online, and if a participant's indicators reveal extreme distress, the dyad will receive an alert suggesting professional help. Thus, empirically supported intervention components will be "crowdsourced" to the general public. This crowdsourcing will reduce barriers to participation and alleviate strain on the existing mental health care system so that it can better serve those who require more intensive professional treatment. As a paradigm challenge, CMH will be more cost-effective, replicable, sustainable, and accessible. I plan eventually to make CMH freely available online and, with participant consent, to collect longitudinal data on its proposed mechanisms (i.e., emotion regulation, mindfulness, social support). These data will help researchers to refine interventions and to better understand the basic processes involved in healthy human functioning. Ongoing data collection and outcomes monitoring will also facilitate continuous improvement of CMH even after it is launched. The objective of this application is to lay the necessary foundation for pilot testing the efficacy of the complete CMH program for various mental illnesses. It has two specific aims: 1. Develop the Web-based training. In consultation with experts, I will create course materials, including instructional videos, text, and self-assessment items. 2. Pilot test the training to determine its acceptability and its effectiveness in teaching the requisite skills for acting in the care provider role for the CMH program. Our working hypotheses are that (a) after completing the training program, participants will perform significantly better at delivering the intervention in a mock CMH session, and (b) that most participants will demonstrate acceptable skill for participation in the full program. If 80% of participants reach acceptability, the training will be considered successful. We are not yet testing the full intervention, but instead first aim to confirm whether online training can teach the identified caregiving skills. This step is needed prior to a full pilot trial because, if the training does not teach these skills, the intervention is unlikely to be effective. A pilot trial would be beyond the scope of this fellowship, but one is planned after the conclusion of the award. The expected outcomes of this project are that CMH's training will be validated and that I will have developed the skills necessary to pursue pilot testing of the full CMH program. CMH is expected to have a positive impact by filling a gap in the mental health care system through treating mild to moderate mental illness and preventing onset and relapse of mental illness for those who are unable or unwilling to seek more traditional treatment.